Multi-Site Randomized Controlled Trial of a Novel Digital Application (DREAMLAND) to Improve Outcomes for Patients with Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
Overview: The goal of this study is to examine the efficacy of a novel digital application (app) for improving
quality of life (QOL) and psychological outcomes in patients diagnosed with acute myeloid leukemia (AML).
Background: Patients newly diagnosed with AML confront a sudden and life-threatening diagnosis, requiring
an immediate disruption of their life and an urgent 4-6-week hospitalization to initiate intensive chemotherapy.
During this hospitalization, they endure substantial physical symptoms due to the side-effects of chemotherapy,
which negatively impact their QOL. Importantly, patients also experience immense psychological distress as
they struggle with the abrupt onset of illness, uncertainty regarding their prognosis, physical and social isolation
during hospitalization, and complete loss of independence. Despite the well-described psychological sequalae
patients with AML experience, interventions to support them during this challenging hospitalization are limited.
Moreover, limited availability of palliative care and mental health clinicians further hinders the scalability and
dissemination of supportive care interventions to address the needs of all patients with AML. We developed a
self-administered novel digital app (DREAMLAND) for patients with AML undergoing intensive chemotherapy.
DREAMLAND includes four modules that focus on: 1) supportive psychotherapy to help patients adjust to the
shock of diagnosis; 2) psychoeducation to manage illness expectations; 3) psychosocial skill-building to promote
effective coping; and 4) self-care. We recently completed a pilot randomized trial demonstrating the feasibility of
DREAMLAND and its promising efficacy for improving patient-reported QOL, anxiety and depression symptoms,
as well as self-efficacy and symptom burden, compared to usual care. Based on these findings, DREAMLAND
received an FDA Breakthrough Device Designation as a promising digital therapeutic for AML.
Research Plan: We propose to conduct a multi-site randomized trial of DREAMLAND versus CERENA (a phys-
ical health promotion control app) in 200 patients with AML undergoing intensive chemotherapy to test the effi-
cacy of DREAMLAND for improving patient-reported outcomes in a large and more diverse patient population.
We will also assess the impact of DREAMLAND on patients’ long-term QOL and psychological outcomes as well
as explore mediators and moderators of the intervention effect on patient-reported QOL.
Environment: This project will be conducted at Massachusetts General Hospital, Duke Cancer Center, and Fred
Hutchinson Cancer Research Center. These sites have the supportive care research and leukemia experience,
infrastructure, and processes to conduct this trial. The MGH research team has the expertise in developing and
testing palliative, supportive care, and digital health interventions for patients with solid tumors and hematologic
malignancies to ensure the successful implementation of this trial across all study sites.
Relevance of Research: Data from this project will be used to obtain FDA approval for DREAMLAND as a
digital therapeutic that can be prescribed to address the immense needs of patients with AML.

Public health relevance
PROJECT NARRATIVE Patients with a new diagnosis of acute myeloid leukemia (AML) confront substantial psychological symptoms as they cope with a sudden and life-threatening diagnosis that requires immediate disruption of their lives and an urgent 4-6-week hospitalization to initiate intensive chemotherapy. Despite their immense burden, interventions to address the needs of this vulnerable population are limited. This proposal seeks to assess the efficacy of a patient-centered, self-administered, digital app (DREAMLAND) for improving patient-reported quality of life and psychological distress during this challenging hospitalization for intensive chemotherapy and in the long-term.